Evaluation of a dual PPAR agonist for treatment of Alzheimer's disease

SUMMARY
Alzheimer’s disease (AD) and related dementias are devastating conditions that affect millions of people, but no
effective treatment options exist. Studies are currently being performed as part of the funded Phase II STTR
parent award to test efficacy of a potential AD therapeutic, OL-003, in two additional animal models and assess
pharmacology and toxicology. The overarching goal of the Phase II project is to generate data that is required
to submit an Investigational New Drug (IND) package to the FDA for clinical trials approval. Due to budget
limitations, critical studies needed for IND approval were not able to be proposed. Therefore, this administrative
supplement seeks to generate additional pharmacokinetic (PK) data within the scope of the parent project that
will contribute to a more complete IND package.
In this administrative supplement, two aims are proposed. In aim 1, PK analysis of two different formulations
of OL-003 will be performed in mice to identify the optimal formulation to be used in IND-enabling studies and
Phase 1 clinical trials. The formulations, consisting of FDA approved adjuvants/excipients that have been shown
to enhance the PK profile of brain-acting drugs, will be compared head-to-head to identify improvements in
solubility and brain distribution of OL-003. In aim 2, OL-003 PK linearity and tissue distribution will be assessed
with increasing dose. Steady state of OL-003 in the brain will be determined by repeated daily dosing in mice
using the selected formulation from aim 1. These data will support the optimal OL-003 dosing strategy to
maintain a safe and therapeutic brain exposure for the treatment of AD. The results from this administrative
supplement will strengthen the IND application and decrease the time to OL-003 first-in-human trials.

Public health relevance
NARRATIVE Alzheimer’s disease (AD) and related dementias are a major worldwide health problem with no truly effective therapeutic options. The purpose of the parent award is to generate data that is required to file an Investigational New Drug (IND) application for approval to investigate OL-003, a potential AD therapeutic, in clinical trials. The studies proposed herein aim to generate additional data within the scope of the parent award that will be used to form a more complete data package for IND approval and increase the likelihood that OL-003 will benefit the AD community and impact the field of AD research.